Investigating how xenobiotics interact with phages to shift energy balance

Project Summary
Obesity is a major public health concern associated with several co-morbidities, such as metabolic syndrome,
type 2 diabetes, and cardiovascular disease. Many prescription medications, including second-generation
antipsychotics (SGAs), increase obesity risk by causing significant weight gain. Our lab studies the widely
prescribed SGA, risperidone, and has shown that weight gain associated with this drug is mediated by the gut
microbiome. Bacteriophages, or phages, are highly abundant in the gut and are important mediators of the gut
microbial community composition. Thus, we investigated how risperidone treatment influences phages in the gut
and found that risperidone treatment leads to the release of phages from bacterial genomes; these phages are
sufficient to drive weight gain and shifts in microbiome composition, and they also have an increased potential
to influence their bacterial hosts’ metabolic state compared to control phages.
While we know that phages are important contributors to risperidone-induced weight gain (RIWG), we have yet
to determine mechanistically how these phages are induced by the presence of risperidone. Temperate phages
are often induced through activation of the bacterial SOS response, leading to the hypothesis that risperidone is
acting as a bacterial stressor that induces the SOS response in gut bacteria, ultimately leading to the release of
phages from the bacterial genomes. This hypothesis will be investigated in Aim 1.
One bacterial species that we found to release phages in response to risperidone is Limosilactobacillus reuteri.
Further, bioinformatics analysis revealed that L. reuteri is significantly depleted in risperidone-treated animals,
suggesting that it may be an important contributor to a lean phenotype. Co-treatment of mice with risperidone
and L. reuteri prevented RIWG and generated a microbiome distinct from that of control animals. Additionally,
reutericyclin (Rtc), a specialized metabolite produced by some strains of L. reuteri, was sufficient to deflect
RIWG, suggesting that L. reuteri deflects RIWG through the release of Rtc. Rtc has known antimicrobial
properties and, like risperidone, is a small molecular xenobiotic leading to the hypothesis that Rtc deflects RIWG
by differentially altering the phageome. This hypothesis will be investigated in Aim 2.
The overall goal of this project is to understand how the presence of xenobiotics can catalyze alterations
in the phageome and determine how these alterations can contribute to changes in energy flux. This work
will take place in the laboratory of Dr. John Kirby in the Department of Microbiology & Immunology at the Medical
College of Wisconsin, a highly collaborative and stimulating environment that is well equipped to perform the
proposed aims. We have designed a training plan that will be beneficial for my scientific and professional growth
and ultimately will position me to reach my goal of becoming an independent biomedical scientist. Altogether,
this project is fundamental for my advancement as an autistic woman in biomedical research, the field of obesity
research, and the generation of microbiome-based therapeutics for xenobiotic-induced weight gain.

Public health relevance
Project Narrative Obesity is a significant risk factor for various health conditions, including metabolic syndrome, cardiovascular disease, and type 2 diabetes; several classes of prescription medication, including second generation antipsychotics (SGAs), increase obesity risk by disrupting the gut microbial community. This project focuses on microbiome shifts caused by risperidone, an SGA that causes weight gain, and reutericyclin, a specialized microbial metabolite that deflects risperidone-induced weight gain. Our findings will reveal how xenobiotic- mediated induction of bacteriophages can lead to shifts in energy flux and will inform the development of phage-targeted therapeutic strategies against the development of obesity in individuals taking prescription medications.